Screen, Treat and Retain Meth-Using People with Opioid Use Disorders at MMT Clinics (STAR-OM)

Research Abstracts
We propose to develop and evaluate optimal combinations of evidence-based interventions (EBIs) to
improve HIV outcomes and reduce methamphetamine use among people with opioid use disorder (OUD) who
are in methadone maintenance therapy (MMT) in Vietnam (STAR-OM study). Over the past decade, the
expansion of MMT has contributed to stemming both HIV and opioid epidemics. However, rising
methamphetamine use threatens these achievements. The twinned epidemics of opioid and
methamphetamine use have also been reported in the US and other countries. Building on our pilot work with
MMT patients in Hanoi, through collaborative work with local MMT providers and patients, we will refine
adapted EBIs to develop an adaptive design that offers an individualized approach to treatment. The adaptive
design includes: (1) Two frontline interventions: 6 weeks of CM then 6 weeks of weekly group educational
sessions (low intensity CM) and 12 weeks of CM (high intensity CM); (2) One (short-term) tailoring outcome:
urine tests negative with meth metabolites in both week 11 and 12 are considered responsive to frontline
interventions; (3) Three alternative interventions: those with positive outcomes will move to 12-week
maintenance stage and receive two daily SMS reminders plus one weekly self-monitoring assessment
message. Non-responders will move to 12-week enhanced treatment stage and are randomized to either
Matrix group counseling only or Matrix group counseling plus CM. We will compare effectiveness of two
frontline interventions and four adaptive interventions with a Sequential Multiple Assignment Randomization
Trial in 200 HIV+ (150 from HCMC; 50 from Hanoi) and 400 HIV- (200 from each city) MMT patients who
report moderate- and high-risk meth use on self-screening with tablet-based ASSIST and/or have urine
positive with methamphetamine metabolites. In each location, the study will stratify participants by HIV status
before randomizing them to one of two frontline interventions. Primary outcomes - including HIV viral
suppression, HIV risk behaviors, and meth use (reported and urine tests) - will be assessed at 12, 24 and 48
weeks. We will calculate the incremental cost effectiveness ratio (ICER) comparing cost-effectiveness between
two frontline interventions as well as among four adaptive strategies. Finally yet importantly, we also conduct
ethnographic observations and in-depth interviews with MMT clinic managers, clinical staff and MMT patients
(N=60, 30 per city) to identify structural, provider and patient-level factors that influence adoption and scale-up
of the adaptive interventions. Findings from this study with Type I Hybrid design to evaluate
EFFECTIVENESS-Implementation will provide valuable evidence to develop treatments in resourced and
resourced-constrained settings to confront the twinned epidemics of opioid and methamphetamine use in the
context of surging HIV epidemic due to drug abuse.

Public health relevance
Public Health Relevant Statement The twinned epidemics of opioid and methamphetamine use have been reported in the US and other countries such as Vietnam. We propose to develop and evaluate optimal combinations of evidence-based interventions to improve HIV outcomes and reduce methamphetamine use among people with opioid use disorders who are in methadone maintenance therapy. Lessons learned from this study may inform the development of responses in the US as well as other resourced and resourced-constrained settings.